FUNCTIONAL VALIDATION OF A PLECTIN-ASSOCIATED ALZHEIMER'S DISEASE PROTEIN NETWORK

Project Summary/Abstract
This proposal describes a five-year mentored laboratory training experience designed to lead to an independent
academic research career dissecting the underlying biology of Alzheimer’s disease (AD). The applicant’s career
goal is to become a prominent scientist in the AD research field by leading an independently-funded research
group. The career development plan includes training designed to broaden the applicant’s scientific skillset,
including: (1) utilizing systems biology approaches to validate protein networks and network hub proteins
associated with AD, (2) employing cross-species analyses to validate components of an AD-associated network
and dissect its underlying biology, and (3) applying translation biology approaches to determine how these
protein networks contribute to AD pathogenesis and identify potential therapeutic targets. This plan incorporates
additional training in leadership, mentorship, grant-writing, and ethics. During a period of mentored research
training, the applicant will engage in skills acquisition, didactic training, seminars, international conferences,
meetings with his mentor and mentorship committee, followed by a transition to independence. The
proposed research seeks to improve our understanding of the underpinnings and pathophysiology of AD by
investigating an AD-associated protein network. We have identified the human M4 protein network that is
significantly associated with AD symptoms and neuropathology. Based on network analyses, Plectin (Plec) was
identified as a potential network driver that best represents the behavior of the entire network. The overall project
goal is to validate and elucidate the role of M4 network by dissecting Plec function in the Drosophila model. My
cross-species approach will powerfully enhance our understanding of Plec and the M4 network, informing a
therapeutic rationale for further studies in mammalian preclinical AD models. This five-year project will take place
primarily at Baylor College of Medicine (BCM), an institution with nationally recognized departments in both
genetics, neuroscience, and AD research, including well-established research efforts. The Department of
Neurology has an outstanding track record of training early stage investigators to become highly successful
translational researchers. The research environment provides the best intellectual environment and available
technology. The proposal provides a broad research experience in systems biology analysis of proteomic data,
cross-species validation of a translationally relevant protein network, and functional characterization of a
proposed network driver and AD therapeutic target. In addition, the proposed career development plan will
prepare this applicant to become an independent scientist and leader in the AD research field.

Public health relevance
Project Narrative Large scale proteomic analysis of Alzheimer’s disease (AD) patients has identified a connected network of proteins associated with AD. To determine whether the M4 protein network and its key hub proteins, including Plectin (Plec) modulates AD risk, this project will dissect Plec’s function in the nervous system and validate the protein network structure using cross-species analysis. My results will determine the function of a predicted AD target in the adult brain, its role in the protein network, and validate protein network structure with the goal of elucidating novel AD pathophysiological mechanisms and develop novel therapeutics.